Integrated Food Safety System Training Delivery and Development

Integrating Food Safety System Training Delivery and Development: Project
Summary
The Association of Food and Drug Officials (AFDO) will lead and implement the
activities under this cooperative agreement to strengthen mutual reliance across
jurisdictions and advance a nationally Integrated Food Safety System (IFSS) and to
support FDA’s implementation of the Food Safety Modernization Act (FSMA). AFDO’s
efforts will enhance regulatory workforce development, improve inspectional
consistency, and modernize training delivery for retail food, manufactured food, produce
safety, and laboratory programs, which ultimately improves public health protection of
the food supply.
AFDO has been a trusted partner to state regulatory food programs since 1896 and is
recognized as a national leader in IFSS training. The Principal Investigator and project
team include seasoned professionals with extensive experience in regulatory program
management, instructional design, and FDA course delivery. Their expertise spans
curriculum development, adult learning, and field-based training for state, local, tribal,
and territorial (SLTT) regulators.
Major activities under this cooperative agreement include:
• Designing and delivering FDA-aligned training courses using FDA/OTED’s
Instructional Systems Design (ISD) methodology to ensure consistency, quality,
and instructional integrity.
• Expanding access to foundational and advanced training through virtual
instructor-led, asynchronous, and hybrid formats.
• Delivering signature high-impact programs such as AFDO’s Inspector Boot
Camp, which offers field-informed, scenario-based foundational training, and
expanding a library of over 30 FDA-aligned courses covering technical,
regulatory, and soft skill competencies.
• Conducting stakeholder-informed research to identify emerging training needs
and barriers to participation.
• Enhancing digital learning tools, including gamified modules and scenario-based
simulations to increase participant engagement.
• Maintaining and improving training infrastructure, including course tracking
systems, instructor onboarding, evaluation processes, and tools like LearnED.
• Collaborating with subject matter experts and state program managers to ensure
training reflects real-world regulatory conditions.
• Promoting workforce development through outreach to colleges and universities
and supporting experiential learning opportunities.
Through these efforts, AFDO will help build a more capable, consistent, and confident
regulatory workforce, aligned with FDA’s FSMA goals and the broader vision of a unified
national food safety system.

Public health relevance
Integrating Food Safety System Training Delivery and Development: Project Narrative The Association of Food and Drug Officials (AFDO) proposes this cooperative agreement to strengthen the national food safety system by advancing workforce competencies, regulatory consistency, and federal-state collaboration. In partnership with FDA/OTED, AFDO will modernize and deliver high-quality, competency-based training to Integrated Food Safety System (IFSS) professionals across all levels of government. AFDO brings proven capacity in instructional systems design (ISD), leveraging FDA- aligned methodologies to design and deliver accessible, scalable training. Through a blend of virtual instructor-led training, asynchronous eLearning, and scenario-based exercises, AFDO ensures that all training is grounded in adult learning theory and responsive to emerging regulatory challenges. Two national initiatives highlight AFDO’s leadership in this space. First, AFDO’s Inspector Boot Camp series has trained thousands of regulators nationwide through immersive, scenario-driven instruction that builds both foundational and advanced inspectional competencies. Second, AFDO has developed and/or updated dozens of regulatory courses in support of FSMA implementation. These include training on both technical and soft skills needed across food program areas such as retail, manufactured food, produce safety, and laboratory oversight. By drawing on its national network, deep subject matter expertise, and longstanding collaboration with FDA and SLTT partners, AFDO will expand training delivery, enhance instructional quality, and address workforce gaps. These efforts will directly support FDA’s vision of a more unified, agile, and effective food safety system.